PROMIS Profile Measures in Older Adults - Identifying Cognitive Thresholds for Reliable and Valid Responses

Summary
The National Institutes of Health (NIH) Patient-Reported Outcomes Measurement Information System
(PROMIS®) measures were developed to provide highly precise and valid measures of patient-reported
outcomes, establish a common metric across chronic health conditions, and enable computerized adaptive
testing. The PROMIS measures have not been widely tested in the older adult population, especially those
aged 80 and older nor among those with Mild Cognitive Impairment (MCI), and Alzheimer’s and Related
Dementias (ADRD). The reliability and validity of responses provided by those with MCI and ADRD on
PROMIS measures is unknown, as is the threshold on cognitive screening tests where self-reported outcomes
data is no longer representative of underlying health status. The Specific Aim of the overall study is to validate
the PROMIS Profile measures in older adults and to identify the threshold where cognitive impairment
invalidates these measures. We will test the utility of the PROMIS Profile measures (29-, 43-, and 57-item
versions) among older adults with varying levels of cognitive impairment to find thresholds (cut-points) where
patient-reported data can no longer be reliably or validly attained. Cognitive levels will be assessed with the
Montreal Cognitive Assessment (MoCA) and the Mini-Mental State Examination (MMSE). A total of 438
subjects will be enrolled from outpatient practices ensuring equal numbers of subjects, ages 65-79 and 80+
years, as well as a spectrum of cognitive function from normal cognition to MCI to ADRD. Qualitative cognitive
interviews in 38 older adults examined patient understanding of individual items and capacity to provide valid
information. Quantitative investigation of thresholds of cognition will be assessed using the PROMIS profile
measures in an additional sample of 400 older adults to identify the cognitive threshold where responses
become inconsistent, unreliable, and invalid. The first administrative supplement expanded the brief cognitive
assessments (MMSE, MoCA) with a) the more sensitive NIH Toolbox Cognition Battery, b) a reading
comprehension measure, and c) the PROMIS Applied Cognition Abilities and Concerns measure to assess
metacognition (awareness of cognitive deficits). This second administrative supplement will provide
additional resources to collect more data on people over age 80 and those with greater cognitive impairment.
These groups were very challenging to enroll during the COVID-19 pandemic due to greater difficulty with
telemedicine during the shutdown, and greater barriers in travelling to the office when in-person visits
restarted. It will also enable expansion of our recruitment to additional clinic settings to recruit more African
Americans, and those with cognitive impairment related to more diverse medical conditions. This study will
result in practical data for immediate translation to clinical practice and for further research on the capacity of
older adults with varying levels of cognitive impairment to provide accurate responses on measures of disability
and psychological distress.

Public health relevance
Narrative This is a study of people with cognitive problems due to Alzheimer’s disease and related dementias. The study focuses on how well people respond to common questions about their symptoms and daily activities. This administrative supplement will provide additional resources to collect more data on people age 80 and older, and those with greater levels of cognitive impairment, who were unable to enroll during the COVID-19 pandemic due to difficulty with remote assessments and hesitancy to come in for in-person visits. The supplement will also expand the study’s racial diversity. Results will help researchers improve outcome measures for people with cognitive problems and in the oldest age groups.